Research Training - Genetics of Substance Abuse

PROJECT SUMMARY
This proposal seeks continued support, via an institutional training grant, for a training program for pre and
postdoctoral fellows who will pursue research careers that focus on genetic influences on substance abuse.
The faculty, from the Institute for Behavioral Genetics (IBG) and collaborating units, is distinguished and active
in research, and IBG scientists have actively pursued studies of genetic influences on substance abuse for
over 50 years. Major substance abuse-related research projects are in progress in both human and animal
behavior genetics. The application of biometrical, statistical, and quantitative genetic techniques, together with
bioinformatics, genome-wide analyses and next generation sequencing, and epigenetics, is providing real
advances in knowledge. Neuro-chemical, -pharmacological, -physiological, and molecular genetic studies, are
providing an understanding of gene function related to behavior. Since our last application, we have added a
major commitment to functional and structural brain imaging as a research tool and have expanded our faculty
and training program accordingly. Our research and training include the use of large scale collaborative studies
that are amassing DNA repositories and rich phenotypic data sets available for studies of substance abuse.
These include the Adolescent Brain Cognitive Development (ABCD) study, for which our training faculty are
PIs of the twin study component, the NIDA Genetics Consortium, the Psychiatric Genetics Consortium, the UK
Biobank, and GSCAN, a genome wide study of over 1 million cases. IBG facilities are available for gene
function and expression studies, and behavioral, biochemical, and neurophysiological studies, and we are
actively pursuing animal model studies of the functional implications of SNPs robustly associated with drug
phenotypes in the human population. To reflect the expanded need for training, particularly for genetics
expertise applied in the context of ABCD, brain imaging, translational research, and `big data' studies, funds
are requested to support 6 pre-doctoral and 3 postdoctoral trainees. Trainees will typically be supported for up
to 3 years. Pre-doctoral trainees receive doctorate degrees from a cooperating academic unit and certification
in behavior genetics. Academic requirements in the training program include training in behavior genetics,
quantitative and biometrical genetics, theoretical and computer-based statistics, molecular genetics,
neuroscience, bioinformatics and genomics, mandatory training in the responsible conduct of research, and
courses on behavioral, brain imaging, and clinical phenotypes. Additional requirements vary according to the
degree granting academic unit. Research is an integral part of training. Postdoctoral trainees also pursue a
formalized program that emphasizes individual research as well as competence in molecular and quantitative
behavior genetics. Other activities in preparation for research careers in substance abuse include: supervision
of students and/or technicians, hosting of seminar speakers and conference organization, guest lecturing, a
weekly journal club, grant writing, and the development of individual professional plans.

Public health relevance
PROJECT NARRATIVE This proposal is to train scientists who will be able to contribute significantly to our understanding of genetic contributions to substance abuse and its consequences. This understanding will lead to new approaches to the prevention of substance abuse and alleviation of its harmful consequences.